Preclinical Evaluation of a Novel ADAM10 Modulator to Treat ColorectalCancer

Abstract
Colorectal cancer (CRC) is the third most diagnosed cancer in the USA and accounts for more than 600,000
deaths annually worldwide, primarily due to relapse with highly aggressive, chemo-resistant disease
characterized by poorly differentiated cancer cells with stem cell-like properties. A common signature of these
chemo-resistant tumors is dysregulation of Notch receptor signaling, as well as upregulation of its
metalloprotease activator, ADAM10. Although small molecule inhibition of either Notch or ADAM10 has been
shown to produce potent anti-tumor effects, these therapeutic strategies have failed in clinical trials primarily due
to systemic toxicities, especially cytotoxic effects on the gastrointestinal tract and musculoskeletal system,
highlighting the need for development of more targeted approaches. We have previously demonstrated that
ADAM10 predominantly exists in an inhibited state in normal tissues but is activated in tumor cells through a
conformational change in the extracellular domain, thus providing a potential target for tumor-specific modulation
of ADAM10 activity. Here, we look to characterize a novel human monoclonal antibody agent (1H5) that
selectively targets an exposed extracellular region of activated ADAM10 on tumor cells. We previously
demonstrated that treatment with a murine version of the antibody (8C7), specific for the activated form of both
mouse and human ADAM10, conferred a significant reduction in tumor burden against human CRC cell lines in
cell culture and transplants in xenograft models, and relapse was prevented when 8C7 was combined with
chemotherapy. The goal of this proposal will be perform in-depth preclinical “go/no-go” experimentation that will
provide a definitive evaluation of ADAM10 monoclonal antibodies as a therapeutic approach. Here, we look to
investigate our murine and human mAb agents at the molecular, cellular, and physiological levels by
biochemically, characterizing their mechanism of action through in vivo assessment of metastatic CRC lesions
in syngeneic immune-competent mouse models (8C7) and through xenograft models using human tumors (1H5).
We hypothesize that through the use of genetic tools combined with in vitro and in vivo models, we can gain
important information that significantly de-risks the clinical development of 1H5-based therapeutic agents as we
move forward clinical trials to treat a broad population of CRC patients. Our research will not only help us move
1H5 toward successful clinical trials, it will also pioneer a new standard to comprehensively study novel
therapeutic agents and identify potential failures early on. The overall goal of this proposal is to fully characterize
a unique therapeutic agent to selectively impair Notch pathway activation in models of CRC to produce potent
but less toxic therapies, advancing only candidates with a greater chance of success through clinical trials.

Public health relevance
Project Narrative Many colorectal cancer (CRC) patients present with highly aggressive, poorly differentiated, chemo-resistant disease often characterized by dysregulation of Notch signaling and upregulation of its regulator, ADAM10. While ADAM10 is recognized as potential promising therapeutic target, therapeutic agents targeting ADAM10 have failed in clinical trials due to their nonspecific activity that leads to severe toxicities, leaving no available effective and tolerable therapies to treat aggressive CRCs. Here, we propose to characterize a newly generated human monoclonal ADAM10 antibody that binds selectively to the ”active” form of the protein found predominantly on cancer cells, and in parallel, unravel of signaling pathways affected using various modes of ADAM10 modulation in order to better understand the mechanisms of both disease attenuation and adverse effects.